Serious game for bullying prevention to prepare students socially for the transition to middle school

Abstract Bullying is an all too common occurrence in our nation’s schools. Research underscores how all involved— bullies, victims, and bystanders—are at elevated risk for negative outcomes in many aspects of a child’s social, emotional, and academic life. Recent reviews of school-based programs demonstrate that social emotional learning (SEL) is a critical ingredient in effective bullying prevention. Unfortunately, logistical barriers (e.g., time, cost, need for trained staff) too often undermine schools’ abilities to implement traditional in-person programming with all students. This SBIR Phase project aims to apply cutting-edge intelligent social tutoring game technology to create a new, evidence-based serious game specifically designed to help late elementary students learn and build the social emotional skills needed to navigate bullying situations and successfully transition to the middle school social environment. The end result of our Phase I and Phase II efforts will be a rigorously tested serious game specifically designed to prevent bullying and prepare students socially for the middle school transition through a safe virtual environment where late elementary students can learn and practice essential SE skills for identifying, managing, and avoiding a variety of bullying situations. In Phase I, we will accomplish three specific aims. First, we will create a serious game prototype with input from 4th and 5th grade students, parents, and educators to select the custom graphic design and storyworld and inform development of five social problem solving scenes depicting various types of bullying situations (i.e., physical, verbal, relational, cyber, and bystander). Second, we will conduct feasibility tests with 4th and 5th grade students and educators who will review and evaluate the prototype. And, third, we will create a full Phase II development and testing plan based on our Phase I findings. Our proposed serious game bullying prevention product will meet a significant market need as the first rigorously tested serious game for bullying prevention to prepare students socially for the difficult transition to middle school. Importantly, the proposed product will benefit from an established channel into the school market as our commercialization partner, Personalized Learning Games, Inc., has committed to include the proposed game in its product line, once fully developed and tested in Phase II.

Public health relevance
Project Narrative Bullying is alarmingly prevalent in our nation’s schools, and decades of research underscore how bullying and peer victimization foster both short- and long-term detrimental effects for all those involved. Bullying in all forms peaks in middle school and research indicates children’s ability to negotiate difficult social situations and adapt socially before the transition directly impacts the degree to which they are able to successfully navigate this difficult transition as well as their subsequent academic, social, and behavioral adjustment. Effective school- based bullying prevention efforts focus on providing instruction and practice in the social emotional skills needed to navigate various bullying situations. Serious games can lower time and cost barriers schools face in implementing bulling prevention programming while also offering an inherently engaging and safe platform students to learn and practice essential social emotional skills. The end goal of the proposed Phase I SBIR is to create and test a prototype serious game for bullying prevention specifically designed to help prepare 4th and 5th grade students for the pivotal transition to middle school.